Systems Genetics Analysis of Resilience to Tauopathy in ADRD

Project summary
Tauopathy is a major component of Alzheimer's disease, frontotemporal dementia, and other Alzheimer's
disease-related dementias. Compared to other proteinopathies, tauopathy most closely tracks with cognitive and
non-cognitive symptoms of these diseases, hinting at a critical role in neurodegeneration. Individual differences
in tau pathogenesis, as well as rate and distribution of progression, largely determine disease presentation.
Interestingly, these differences appear to be genetically controlled. There are a number of challenges to
identifying genetic modifiers of tauopathy in human populations (including relatively few individuals carrying
causative tau mutations, the reality of prohibitively complex human genomes, and the likely contribution of many
small-effect size variants). Therefore, a well-designed mouse genetic reference panel may be key to overcoming
these challenges. Here, we propose to combine a well-characterized mouse model of tauopathy, the PS19
transgenic line (P301S MAPT mutation), with the genetically diverse BXD family of mice, to establish the FTD-
BXD population of mice in order to interrogate genetic and molecular modifiers of tauopathy. The FTD-BXD mice
will allow us to identify genetic factors that underlie resilience to tauopathy; such resilience factors may represent
novel therapeutic targets to prevent, delay, or treat FTD and other tauopathy-dominant ADRDs.

Public health relevance
Project Narrative Tauopathy is a primary feature of a majority of neurodegenerative disease cases, and it closely predicts clinical progression of disease. Understanding the factors that underlie individual differences in rate and distribution of pathological tau progression may reveal therapeutic targets that could promote resilience to tauopathy. We propose to use novel, powerful mouse models to discover robust molecular modifiers of tauopathy, which will have therapeutic implications for Alzheimer's disease, FTD-tau, and a variety of other related neurodegenerative diseases.